Novel determinants of introspective accuracy and confidence in schizophrenia-spectrum disorders: A mixed methods investigation

Project Summary: Introspective accuracy (IA; i.e., how individuals estimate their abilities and skills) and
confidence about performance are promising determinants of real-world functional outcomes for people with
schizophrenia-spectrum disorders (SSDs). Yet, the mechanisms underlying IA and confidence are currently
unclear. One area with promise as a potential determinant of IA and confidence is sleep. Sleep difficulties are
highly prevalent in people with SSDs, and early work suggests that self-reported sleep quality may be related to
IA and confidence about task performance among those with SSDs. No studies to date have examined these
relationships using objective sleep assessments, and it is unclear how sleep may impact IA and confidence day-
to-day. While existing work points to sleep as one possible determinant of IA and confidence, there may be
additional factors related to IA and confidence in this group that have not been previously explored. No research
to date has assessed participants’ perceptions of factors impacting their IA and confidence, or their
understanding of why they might over or underestimate their abilities. The current study will address this question
using qualitative interviewing. This data may have important implications for current mechanistic models of IA
and confidence, as factors may be identified through qualitative methods that have not been previously
considered. This study aims to fill these gaps in the literature by assessing 1) relationships between objective
sleep quality, IA, and confidence, 2) participants’ understanding of factors impacting their IA and confidence, and
3) whether relationships between sleep, IA, and confidence are stronger among SSD participants as compared
to healthy control (HC) participants. Sixty participants (40 people with SSDs and 20 HCs) will complete
comprehensive assessments of IA and confidence for social cognition and neurocognition. After this visit,
ecological momentary assessment (EMA) via a smartphone app will be used to assess IA and confidence 7
times per day over a one-week period. Fitbits will also be provided to participants, which will be used to collect
objective sleep data during the one-week period of EMA data collection. Following this one-week sleep and EMA
period, a subset of SSD participants (n = 25) will answer qualitative questions about their perception of factors
influencing their IA and confidence ratings. This proposed project aligns closely with NIMH 2024 Strategic Plan,
Strategy 2.2.A (Determining early risk and protective factors, and related mechanisms, to serve as novel
intervention targets). Results from this study will aid in understanding the mechanisms underlying IA and
confidence about performance among people with SSDs, which will inform intervention efforts aimed at improving
everyday functioning in this population.

Public health relevance
Project Narrative Introspective accuracy (IA) and confidence about performance have been identified as important predictors of functional outcomes for people with schizophrenia-spectrum disorders, but the mechanisms underlying IA and confidence are currently unclear. The proposed project will advance our understanding of determinants of IA and confidence by using a mixed methods approach to investigate sleep as one possible determinant using ambulatory assessment of sleep and ecological momentary assessment, while also incorporating qualitative methods to identify novel determinants. Results from this study will inform current mechanistic models of IA and confidence as well as interventions aimed at improving daily functioning for people with schizophrenia-spectrum disorders.